Impact and sustainability of a digitally-based diabetes prevention program

Project Summary/Abstract
Prediabetes and obesity are major public health issues that disproportionately affect racial/ethnic minorities and
low-income individuals in the United States (US). Approximately 84 million American adults have prediabetes.
The recent increased prevalence of prediabetes is caused largely by the global epidemic of obesity. In the U.S,
the prevalence of obesity was recently reported at about 40% adults. With the growing prevalence of obesity in
the U.S., prediabetes is expected to become an even greater public health challenge. The Diabetes Prevention
Program trial and other large trials have shown that a moderate amount of weight loss achieved by reducing
total caloric intake and increasing physical activity can prevent or delay the onset of type 2 diabetes.
However, these prevention programs involving in-person counseling can be expensive to implement and
sustain in clinical or community settings over extended periods of time. The rapid rise of sophisticated
digital devices (i.e., mobile applications, wireless activity trackers, social network) provides an opportunity
to transform the way health care team deliver a diabetes prevention and weight loss program. These digital
technologies are inexpensive and widely available and can reach large numbers of adults with prediabetes and
obesity. However, despite their popularity and availability, the vast majority of individuals will stop using them
within weeks because of lack of systematic behavior change approach (i.e. setting personalized short-term and
long-term goals).Therefore, an urgent need exists in successfully incorporating these inexpensive digital devices
into a diabetes prevention and weight loss program and sustain its effect over time. The goal of this project is to
assess the effect and sustainability of a digitally-based diabetes prevention program in English or Spanish
speaking adults with prediabetes and obesity. The primary outcomes are change in percent body weight and
HbA1c from baseline, 5, and 12 months. In this proposed 12-month randomized controlled trial, we will randomize
255 participants into one of 3 groups with a 1:1:1 ratio: 1) a Control (usual care), 2) a Regular intervention group,
and 3) a Plus group. While both the Regular and Plus group will receive a 5-month diabetes prevention
intervention in an identical fashion, only the Plus group will receive a 7-month maintenance intervention. The
Control group will receive an American Diabetes Association lifestyle brochure and wear an activity tracker, but
no intervention will be provided. Our research team seeks to shift the current paradigm, by moving to the use of
commonly used digital technology for diabetes prevention and weight loss programs, and test its sustainability.
We believe that the findings from this RCT will provide new insights into how to design interventions as well as
other lifestyle interventions.

Public health relevance
Project Narrative Prediabetes and obesity are major public health issues that disproportionately affect racial/ethnic minorities and low-income individuals in the United States. The goal of this project is to assess the impact and sustainability of a digitally-based diabetes prevention program in changes in percent weight and HbA1c in English or Spanish speaking adults with prediabetes and obesity over the 12-month period.